Telemedicine Consultations to Improve Care Quality of Pediatric Hospital-to-Hospital Transfers

PROJECT SUMMARY / ABSTRACT
The project objective is to enhance the implementation of telemedicine consultations for pediatric hospital
transfers. This award provides the necessary support to strengthen the parent K23 (K23HD101550, PI:
Rosenthal) pilot trial by: (Aim 1) Applying quality improvement (QI) methods to promote the successful
achievement of the three pilot trial feasibility objectives and (Aim 2) applying the intervention evaluation
framework RE-AIM (Reach, Effectiveness, Adoption, Implementation, Maintenance) to conduct a mixed
methods evaluation of the pilot trial’s telemedicine intervention. Our team has expertise in telemedicine
interventions, clinical trials, QI, mixed methods, evaluation frameworks, and advanced statistical analyses.
This supplement provides hands-on experiences for mentored training of two women early investigators. The
trainee is Dr. Hoyt-Austin, a Hispanic researcher with a long-term goal to be an independent investigator in
systems-level interventions to improve breastfeeding outcomes after birth hospitalization discharge. The
primary mentor and candidate for this supplement is Dr. Rosenthal, a K23 awardee developing research
leadership skills as part of her K23 mentored training plan. We propose a mentoring family, whereby the
“grand” mentors are Drs. Young and Brown. Dr. Young is Dr. Rosenthal’s K23 mentor with expertise in
research leadership and patient- and family-centered outcomes research using health information technology.
She will mentor Dr. Rosenthal is mentoring Dr. Hoyt-Austin’s research activities. Dr. Brown has expertise in
mentorship that increases inclusion and diversity in the research community. She will oversee Dr. Rosenthal’s
inclusive and culturally humble mentoring skill development.
We propose a training plan for Dr. Hoyt-Austin to develop skills in (1) QI methods, (2) qualitative methods,
and (3) implementation and evaluation of telehealth interventions. These skills will give her the foundation
to write her K23 proposal to test a telehealth intervention to improve breastfeeding outcomes. We also propose
a training plan for Dr. Rosenthal to develop skills in (1) inclusive team science environments and (2)
racially and culturally humble mentoring relationships. Dr. Rosenthal has demonstrated strong mentorship
to trainees from groups underrepresented in the biomedical sciences. However, she has never been mentored
in her mentorship. Enhancing mentoring skills, with an emphasis on mentoring trainees from underrepresented
groups, is an integral aspect of research leadership and Dr. Rosenthal’s success as an investigator who
supports the career development of a diverse research workforce by promoting cultures of equity and inclusion.
Completion of this proposal will provide valuable data that will be used in Dr. Rosenthal’s R01 application. It
will enhance the career development of two women early investigators, one who is Hispanic. It will also result
in a UC Davis Mentoring Academy for Research Excellence workshop to disseminate the mentor family
concept to achieve widespread and sustained impact on promiting outstanding mentorship to diverse trainees.

Public health relevance
PROJECT NARRATIVE This proposal enhances the implementation of telemedicine consultations for pediatric hospital transfers using quality improvement methods and a mixed methods intervention evaluation framework. It simultaneously provides mentored training of two early investigators using a “mentor family” concept to promote inclusive and culturally humble mentorship.